Glycogen Synthase Kinase 3 beta in liver ischemia reperfusion injury

Project Summary
Ischemia reperfusion injury (IRI) is a major complication after liver surgery. In liver transplantation, it is
a major risk factor for both acute and chronic graft rejection and restrains the use of marginal donors. Liver
inflammatory immune response drives the pathogenesis of IRI. Despite the progress in studies of cellular and
molecular mechanisms of the response, questions regarding to the potential distinctive roles of tissue resident
vs. infiltration macrophages (iMФs), and the resolution of liver IRI remain to be defined.
Glycogen synthase kinase 3β (Gsk3β) is a unique signaling kinase that it differentially regulates pro-
and anti-inflammatory gene programs in MФs upon innate stimulations. It has been shown in a murine liver
partial warm ischemia model that both Gsk3 inhibitors in WT hosts and myeloid Gsk3β deficiency protect livers
from IRI via an AMPK- IL-10-dependent mechanism. The clinical relevance of AMPK in liver ischemia has
been documented recently in hepatic tumor resection. Preliminary experiments of this proposal have found that
Gsk3β also regulates the resolution of liver IRI. In fact, Gsk3β regulates liver inflammatory immune activation
and resolution by targeting distinctive populations of liver MФs. KCs depletion diminished the liver protective
phenotype in myeloid Gsk3β KO mice against IR. However, the recovery of liver IRI remain accelerated in
these KC-depleted KO hosts, indicating that Gsk3β regulates iMФs in resolving tissue inflammation. Current
proposal will dissect mechanisms of Gsk3β regulation of these two types of MФs at different stages of liver IRI.
IR-induced liver inflammatory immune activation is characterized by infiltration and activation of MФs
from peripheral (iMՓs), as well as necroptotic depletion and pro-inflammatory conversion of tissue resident
KCs. In liver inflammation resolution, MФs repair hepatocellular damage and clear infiltrated neutrophils via
Tyro3-Axl-MerTK (TAM) receptor tyrosine kinase (RTK)-mediated efferocytosis. Macrophage necroptosis and
efferocytosis potently regulate their activation and differentiation. Gsk3β promotes stress-induced cell death
and regulates TAM expressions in MФs. The proposal will test the hypothesis that Gsk3β regulates KC
necroptosis via AMPK and pro-inflammatory immune activation via Mer RTK; and Gsk3β
inhibition/inactivation facilitates iMФ conversion from pro-inflammatory to reparative type by
enhancing Axl-mediated efferocytosis and immune regulatory signaling.
Two specific aims are designed to address how Gsk3β regulates KC inflammatory activation, and iMФ
reprogramming/functions, in the activation and resolution stages of liver IRI, respectively. Results of these
experiments shall offer fresh new insight into immune regulatory functions of Gsk3β in MФs in both the
activation and resolution of liver inflammation and injuries and provide rationales for novel therapeutic
strategies to restore liver homeostasis in patients.

Public health relevance
Project Narrative Ischemia and reperfusion injury (IRI) is an unresolved clinical problem affecting many patients after liver surgery and transplantation. This proposal studies functions of glycogen synthase kinase 3beta (Gsk3β) in macrophages in liver inflammatory immune responses against IRI. Results will further our understanding of the disease mechanism and provide us refined therapeutic rationales to ameliorate liver IRI in patients.